ACTG A5047: PROTEASE INHIBITORS /LIPID LOWERING INTERACT

To investigatoe the effect of ritonavir (RTV) and saquinovir (SQV) on the pharmacokinetics of pravastatin, simvastatin, and atorvastatin and to evaluate teh effect of pravastatin on the disposition of nelfinavir and its M8 metabolite.